Core 1: Tumor and Microenvironment Heterogeneity Core (TMH Core)

PROJECT SUMMARY – Core 1: Tumor and Microenvironment Heterogeneity Core
The central hypothesis driving efforts of the TMH Core is that immune and other stromal cells in the tumor
microenvironment (TME) contribute to both inherent and acquired therapeutic resistance in PDA. Such cells vary
phenotypically, functionally, metabolically, and spatially within the TME, creating distinct niches. For example,
functionally specialized immune cells (e.g., macrophages, T cells, neutrophils) are common within the TME and
can promote or suppress tumor growth. Likewise, cancer associated fibroblasts (CAFs) contribute to extracellular
matrix formation, tumor invasion/metastasis, and T cell exclusion, and can be subdivided into myofibroblastic
CAFs (myCAFs) and inflammatory CAFs (iCAFs) that differentially affect tumor growth and therapeutic
resistance. Thus, characterizing cellular and functional heterogeneity and TME localization, and understanding
how they contribute to therapeutic resistance is key to developing effective therapies. Utilizing expertise in single
cell transcriptomics, epigenomics, functional assays, and digital spatial profiling (DSP), the Core will interrogate
how cellular diversity and localization contribute to therapeutic resistance in PDA.
The TMH Core will support the individual Projects in their efforts to interrogate the TME and tumor-TME
crosstalk with state-of-art approaches and by providing expertise in genomics, bioinformatics, and immunology.
The TMH Core will provide services that are unavailable in existing Salk Institute Cores, and therefore fulfill an
unmet need. In Aim 1, the TMH Core will map the spatial heterogeneity of tumor and stromal cells in human
PDA via DSP (NanoString) to correlate phenotypes with specific tumor niches. In Aim 2, the Core will functionally
characterize immune cells and inflammatory cytokines in the TME via flow cytometry and use Isoplexis IsoSpark
for single cell-secretome analysis and multiplex cytokine assays. In Aim 3, the Core will provide an integrated
platform of single-cell RNA and ATAC sequencing to define the functional heterogeneity of tumor and stromal
cells in PDA and to understand how this heterogeneity contributes to and/or is affected by therapeutic responses.
These aims will support the goals of the projects to elucidate mechanisms of therapeutic resistance in PDA
through epigenetic changes (Project 1), extracellular signaling (Project 2), and AMPK driven autophagy
(Project 3). The TMH Core will collaborate with the Mouse Models Core and the Human Specimen and
Organoid Core to design novel experiments and incorporate mouse and human organoid datasets to decipher
the role of stromal and tumor cells in PDA resistance to therapy. Moreover, the TMH Core will work closely with
the Biostatistics Unit within the Administrative and Biostatistics Core to ensure rigorous state-of-the-art
preprocessing and analysis pipelines. In combination with the efforts of the Projects and other Cores, the TMH
Core will not only elucidate the roles of tumor and stromal cells in therapeutic resistance in PDA, but also provide
insight into how stromal cells are co-opted and coordinated by the tumor. These studies will inform the treatment
of PDA by identifying which compartments can be therapeutically rewired to enhance therapeutic efficacy.

Public health relevance
PROJECT NARRATIVE – Core 1: Tumor and Microenvironment Heterogeneity Core The Tumor and Microenvironment Heterogeneity Core (TMH Core) will provide essential support for all three Projects in their efforts to delineate tumor and stromal cell programs that underlie therapeutic resistance in pancreatic ductal adenocarcinoma (PDA). Specifically, the TMH Core will assist with digital spatial profiling of tissues, quantitative and functional characterization of tumor immune cells, and single-cell transcriptomic and epigenomic experiments, as well as provide the necessary bioinformatic and computational support to effectively utilize the resulting data. In combination, these services will facilitate the determination of how heterogeneity in cell type-specific function and localization contributes to therapeutic resistance in PDA.